Nuclear Architecture, NcRNAs and Epigenetics in Transcriptional Regulation by ER

Project Summary Estradiol, which acts through the Estrogen Receptor alpha (ERα), is essential for the development and homeostasis of female reproductive function, exerting critical control of many transcriptional programs, including these regulatory proliferation, and metabolism. The molecular mechanism used by ERα to mediate coactivator/corepressor exchanges in gene activation has been reasonably well elucidated. ERα, chromatin modifiers and dynamic positioning of particular loci are all essential for establishing precise transcriptional regulation and achieving the correct patterns of gene expression. However, it is not clear how these factors are spatially regulated in distinct subnuclear structures and how this regulation may contribute to gene regulation. Our recent findings demonstrated a signal-induced relocation of the transcription units from a transcriptional repressive compartment to a permissive environment. I hypothesize that non-coding RNAs (ncRNAs) TUG1 and NEAT2 control ERα target genes to relocate from the transcriptional repressive Polycomb bodies (PcGs) to the gene activation milieu of the interchromatin granules, by selectively interacting with methylated and unmethylated Polycomb 2 protein (Pc2) present on ERα target gene promoters. To address this long-term goal, I propose to investigate the hypothesis from three specific aims: 1) to define non- histone methylation/demethylation events and ncRNAs as a novel molecular strategy responsible for genome- wide ERα transcriptional programs; 2) to determine the potential role of two ncRNAs, TUG1 and NEAT2, located in PcGs and interchromatin granules, respectively, in controlling relocation of ERα target genes between these two subnuclear structures, depending on the status of Pc2 methylation in response to estrogen; 3) to investigate the potential allosteric role of ncRNA in modulating the ability of readers of the histone code, such as Pc2, to recognize histone tail modifications. To achieve these aims, I propose to define the genome-wide location of methylated vs. unmethylated Pc2 by ChIP-Seq analysis using specific antibodies and the functional roles of Pc2 or other active readers and ncRNAs in controlling the ERα transcriptome by a combination of GRO-Seq, RNA-Seq analysis and siRNA knockdown strategies. I will also investigate the potential relocalization of ERα-regulated genes from PcG bodies to interchromatin granules upon E2 stimulation and the underlying mechanisms, by which the binding of TUG1 or NEAT2 ncRNAs directs the preference of Pc2 recognition of histone tail modification. Taken together, the proposed study evaluates a new concept that ERα target gene loci relocate between functionally distinct nuclear architectural structures and the roles of several novel modulators that play a critical role in ERα target gene regulation. These findings will provide innovative targets for drugs development for a number of intriguing therapeutic implications. Based on the extensive preliminary data, I am confident of accomplishing these aims in the period of the award and emerging as an Independent Investigator.

Public health relevance
Project Narrative It has been well established that estrogen plays important roles in promoting mammary gland development, regulating transcription and metabolism, and many pathological conditions. While much is understood about actions of Estrogen Receptor, additional unexplored molecular strategies appear to contribute to the critical aspect of estrogen function. The proposed studies in this application dissect the control of estrogen receptor target gene expression from an innovative view that incorporates three-dimensional context of nuclear architecture, epigenetic modifications and novel non-coding RNAs, which will uncover new approaches to treat estrogen-related disease using small RNAs to target ncRNA transcripts. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Estradiol, which acts through the Estrogen Receptor alpha (ERα), is not only essential for the development and homeostasis and the female reproductive function, but also regulates a wide array of transcriptional programs, including these regulatory proliferation, and metabolism, critical for glucose metabolism and homeostasis[1-3]. Molecular mechanisms by which ERα mediates coactivator/corepressor exchanges in gene activation has been rather well elucidated[4, 5], with ERα, chromatin modifiers and dynamic positioning of particular loci all playing essential roles in establishing precise transcriptional regulation and achieve the correct patterns of gene expression. However, it is not clear how these factors are spatially regulated in distinct subnuclear structures and how this regulation may contribute to gene regulation required for homeostasis and normal metabolic function. Our recent findings demonstrated that long-range gene regulation might involve the signal-induced relocation of the transcription units from a transcriptional repressive compartment to a permissive environment. We showed that ncRNA TUG1 and NEAT2 cause the growth control genes to relocate from the transcriptional repressive environment interacting with co-repressor complexes in Polycomb bodies (PcGs) to the gene activation milieu of the interchromatin granules, by selectively interacting with methylated and unmethylated Polycomb 2 protein (Pc2) present on growth control gene promoters, respectively. The Jumonji domain containing protein KDM4B, which could serve as a potential demthylase of Pc2, functions as ERα cofactor and facilitate mammary gland development and breast cancer proliferation[6]. Furthermore, our preliminary data demonstrate that Pc2, and ncRNA TUG1 and NEAT2 affect ER target gene expression dramatically. Thus, I propose to examine the hypothesis that ER-targeted genes are regulated, in part, by the dynamic ligand- dependent relocation from PcGs to interchromatin granules involving the functional interplay between the non- histone Pc2 methylation events and that the resultant specific ncRNA associations, thereby serving to integrate actions of transcription factor/co-regulators, non-histone protein methylation, and ncRNAs resident in distinct subnuclear architectural structures to achieve enhanced, coordinated activation for ERα target genes. The proposed study will provide quantitative, digital and real-time database information, and will provide new insights into ERα regulated transcriptional mechanisms. Specific Aim 1: To define non-histone methylation/demethylation events and ncRNAs as a novel molecular strategy responsible for genome-wide ERα transcriptional programs. To explore this hypothesis, I propose to define the genome-wide location of methylated vs. unmethylated Pc2 in breast cancer cells by ChIP-Seq analysis using our successfully developed antibody specifically against methylated Pc2 (¿Pc2K191me2) and unmethylated Pc2 (¿Pc2K191). I will further examine the functional roles of Pc2 methylation/demethylation in ERα transcriptome by a combination of GRO-Seq and RNA-Seq analysis upon siRNA removal of Pc2 or ncRNA TUG1 and NEAT2. Specific Aim 2: To determine the potential role of ncRNAs, TUG1 and NEAT2, located in PcGs and interchromatin granules, respectively in controlling relocation of ERα target genes between these two subnuclear structures, depending on the status of Pc2 methylation in response to E2. The requirement of Pc2 on ERα target gene activation suggests the possibility of ligand-dependent interchange of ERα transcription units between transcriptionally repressive and permissive subnuclear structures. I propose to demonstrate that ERα-regulated genes relocate from transcription repressive PcG bodies to transcription permissive interchromatin granules upon E2 stimulation by performing Immuno-FISH assays in normal mammary gland epithelial cell line. The possible roles of ncRNAs TUG1 and NEAT2 in controlling this relocation process will be examined by immuno-FISH upon siRNA depletion of TUG1 and NEAT2. Specific Aim 3: To investigate the potential allosteric role of ncRNA in modulating the ability of "readers" of the histone code, such as Pc2, to recognize histone tail modifications. As a component of the transition to R00, I propose to understand the mechanisms by which Pc2 methylation and specific ncRNAs recognize ERα target gene loci for repression or activation, I will test my hypothesis that the binding with TUG1 or NEAT2 ncRNA not one facilitates the association between methylated/unmethylated Pc2 and histone tail modification on promoters of ERα target genes but also "switches" Pc2 reading of histone repressors vs. activation marks by performing in vitro histone peptide array assay and in vivo two-step ChIP analysis.